PROTEIN TRANSLATION INITIATION FACTOR 4D;STRUCTURE, BIOSYNTHESIS AND CONTROL

Eukaryotic protein translation initiation factor 4D (eIF-4D) contains one residue of hypusine and appears to be the only cellular protein with this unique amino acid. Hypusine is produced posttranslationally by transfer of the butylamine portion of the polyamine spermidine to a lysine residue in the eIF-4D precursor and subsequent hydroxylation. These findings reveal a novel cellular metabolic pathway.